TRIAL OF IV WF10 (TCDO) IN PATIENTS WITH LATE STAGE HIV DISEASE

This study is determining the effect of WF10 TCDO (tetrachlorodecaogygen) anion complex, administered in four treatment cycles on the clinical progression in adult patients with late-stage HIV disease.